Evolution and targeting of the functional states of glioblastoma

Project Summary
The application is focused on glioblastoma multiforme (GBM), one of the most lethal forms of human cancer for
which the massive knowledge generated by genomic data has provided little therapeutic improvement. One key
element in the success of clinical studies for cancer patients is the selection of homogeneous groups of patients
harboring tumors that share identifiable functional vulnerabilities rather than general biomarkers. In GBM, the
lack of a functional classifier has hindered the targeting of fundamental cancer-driving mechanisms in well-
defined patient subgroups, leading to discouraging results. The proposal is founded on a novel classification of
GBM that we have recently proposed. Different from previously established marker-based classification, the new
classifier is centered on functional activities of cancer cells that we identified by single cell transcriptomic
analysis. The classifier was validated in several cohorts of bulk primary GBM and includes four subtypes, two
linked to neurodevelopmental programs, neuronal and proliferative-progenitor, and two characterized by
divergent metabolic activities, mitochondrial and glycolytic-plurimetabolic. Notably, the mitochondrial subtype is
endowed with a distinct sensitivity to oxidative phosphorylation inhibition and is associated with a better survival,
while the glycolytic-plurimetabolic subtype is characterized by redundant metabolic activities. Our preliminary
analysis revealed that each functional GBM subtype is association with biologically coherent proteomic and
phosphoproteomic features. In this application we will combine innovative computational tools and state-of-the-
art experimental models in vitro and in vivo to study the impact of functional cell states of GBM in therapy
resistance. We built the research plan with the following aims: i) examine and target the plasticity of the
neurodevelopmental glioma states under therapy pressure and the cross-talk with signals from the
microenvironment; ii) determine how mitochondrial cells adjust to therapy pressure when treated with
mitochondrial inhibitors and the mechanism of induced resistance; iii) retrieve therapeutic intervention points
from proteomic data focusing on DNA-PK and PKCd, two protein kinases active selectively in the
proliferative/progenitor and glycolytic/plurimetabolic subtypes of GBM, respectively. Experimental validations will
be applied to these nodal factors and will be performed by our laboratories, which in the course of many years
have generated and perfected the array of experimental tools including sequence-annotated patient-derived
models to pursue each question. By integrating novel computational and experimental platforms to study the
evolution of distinct GBM subtypes, the proposal is conceptually and technically innovative. The successful
outcome of this proposal will be the delivery of key information to decipher evolving tumor dependencies under
treatment and accurate therapeutic strategies specifically tailored to distinct subgroups of GBM patients.

Public health relevance
Project Narrative Although advances have been made in the understanding of the pathogenesis of glioblastoma multiforme, this knowledge has not been translated into encouraging outcomes. We have introduced a new classification of glioblastoma that highlights the fundamental functional states of glioblastoma cells and delivers prognostic and therapeutic information. This grant proposes to study evolution of glioma cellular states, investigate the changes of cell states under therapy pressure, and test points of interventions for targeted therapeutics identified by integrating genomics and proteomics.